A Randomized Factorial Trial of Varenicline with Nicotine Lozenges and a Smartphone Medication Adherence Intervention to Promote Smoking Cessation

Project Summary
Although the prevalence of smoking has declined among U.S. adults, smoking remains the leading preventable
cause of cancer incidence and mortality. Quitting smoking increases life expectancy, and quitting at an earlier
age is associated with more years of life gained. Effective pharmacotherapies to aid cessation are available, and
the combination of behavioral support with pharmacotherapy optimizes cessation outcomes. Varenicline is an
effective, first-line smoking cessation treatment, and recent research has investigated combination
pharmacotherapy to improve the modest quit rates observed with monotherapy. The findings of two meta-
analyses have indicated that varenicline combined with the nicotine patch was more effective than varenicline
alone for smoking cessation However, no published studies to date have evaluated the combined impact of
varenicline and oral nicotine replacement therapy (NRT) on smoking cessation in a randomized trial. Oral NRT,
such as nicotine lozenges, can provide acute relief from cravings/withdrawal, and offers individuals the flexibility
to deliver nicotine quickly, in contrast with the continuous, passive, and slow-acting delivery of the nicotine patch.
Nevertheless, in clinical trials of other combination pharmacotherapies, participants’ adherence to of oral NRT
has been suboptimal, making it difficult to determine whether there is an added benefit. Given the near-ubiquity
of smartphone ownership (85% of U.S. adults), it is plausible that smartphone-based medication adherence
interventions could have a positive influence on pharmacotherapy adherence and smoking cessation. This
investigative team has demonstrated the feasibility and potential efficacy of using combination varenicline plus
oral NRT treatment to promote smoking cessation in a pilot factorial randomized trial. Likewise, pilot findings
showed that medication adherence and smoking cessation rates were higher among those who received
smartphone-based medication reminders than those who did not. The proposed study will enroll 496 adults who
smoke cigarettes daily. The study will employ a 2x2 factorial design in which participants will be randomized to
one of four combinations of two treatment factors: 1) pharmacological treatment (varenicline + nicotine lozenges
vs. varenicline alone) and 2) smartphone medication adherence intervention (smartphone-based smoking
cessation app with vs. without adherence components). The primary study outcomes will be biochemically-
confirmed 7-day point prevalence abstinence at 26 weeks after a scheduled quit date, and medication adherence
over the 13-week treatment period. Smartphone-based daily diaries will be employed to assess daily smoking
and medication adherence. Notably, the proposed study will employ entirely remote assessment and treatment
delivery strategies. Exploratory analyses will evaluate the potential interaction between medication type and the
smartphone adherence intervention, and compare the influences of pharmacological treatment type and the
medication adherence intervention on weekly physical symptoms (e.g., withdrawal, medication side effects). The
overarching goal of the proposed research is to improve smoking cessation treatment and decrease cancer risk.

Public health relevance
Narrative Although the prevalence of smoking has declined among U.S. adults, smoking remains the leading preventable cause of cancer incidence and mortality. The purpose of the proposed study is to evaluate: 1) the efficacy of combination varenicline plus nicotine lozenges relative to varenicline alone for smoking cessation, and 2) the impact of a smartphone-based medication adherence intervention on medication adherence and smoking cessation. Study findings may lead to new evidence-based treatment options that improve smoking cessation rates and reduce tobacco-related cancer risk.